TREATMENT OF HYPERTENSION IN PREGNANCY

The purpose of this study is to test the relationship between increased cardiac output and renal blood flow (RBF) in preeclampsia by measuring the effects of B-blockade on cardiac output, RBF and microproteinuria.